CLINICAL RESEARCH COORDINATING CENTER FOR THE NIDA CTN. PERIOD OF PERFORMANCE: 08/14/2015-08/13/2020. N01DA-15-2243.

The objective of this contract include a wide range of research support services to aid NIDA in its goal of establishing and operating NIDA's Clinical Trials Network.